Implication of histone H4 LRS mutations in translesion synthesis and UV mutagenesis

PROJECT
SUMMARY/ABSTRACT
The solar ultraviolet (UV) is the most pervasive carcinogen in our natural environment. Translesion
synthesis (TLS) is a DNA damage tolerance mechanism that utilizes specialized DNA polymerases to bypass
UV and other replication-blocking lesions, often leading to mutagenesis. Somatic mutations resulting from TLS
of unrepaired UV lesions are the major causes for essentially all skin cancers, especially melanoma. Indeed,
melanoma
building
associated with UV exposure has the highest number of somatic mutations per tumor. The basic
block of eukaryotic chromatin is the nucleosome, which consists of DNA wrapping around a histone
octamer comprised of one (H3-H4)2 tetramer and two H2A-H2B dimers. PCNA is a hub protein that mediates
DNA replication, replication-coupled nucleosome assembly, and TLS. LRS isa nucleosome domain composed
of
mutations in S. cerevisiae. The
certain residues of histones H3 and H4.
H4 LRS mutations mostly or entirely embedded in the nucleosome, but not those
We identified multiple UV sensitive or resistant histone H4 LRS
on the nucleosome surface, attenuate TLS and UV mutagenesis. The TLS-deficient H4 LRS mutations globally
destabilize chromatin structure, but do not affect PCNA ubiquitination, a modification known to be required for
TLS, indicating that they affect a TLS step downstream of the PCNA modification. To date, studies on how
chromatin structures modulate TLS and mutagenesis have been scarce, if not nonexistent. It has been generally
assumed that chromatin organization passively inhibits TLS. Our finding challenges the assumption and
indicates that a chromatin feature in the LRS is required for efficient TLS. Our finding offers an important clue for
unraveling the long-standing enigma of how chromatin structures modulate TLS and mutagenesis. The goal of
this project is to elucidate how the histone H4 LRS mutations attenuate TLS and UV mutagenesis. We
hypothesize that the TLS-deficient H4 LRS mutations compromise replication-coupled nucleosome assembly
and post-assembly nucleosome stability upstream of DNA lesions, thereby attenuating the retention of PCNA
and the recruitment of TLS polymerases. We will determine how the TLS-deficient histone H4 LRS mutations 1)
affect nucleosome occupancies upstream of UV lesions, 2) affect the retention of PCNA and the recruitment of
TLS polymerases, and 3) functionally interact with histone H3-H4 chaperones, which act at different steps of the
replication-coupled nucleosome assembly process, to affect TLS and UV mutagenesis. Findings from the project
will form the basis for future elucidation of how nucleosome features crosstalk with histone chaperones and local
genomic features to modulate the genomic landscape of TLS and mutagenesis. Also, the study may be
informative for identifying new targets for the treatment and/or prevention of cancers, especially melanoma.

Public health relevance
PROJECT NARRATIVE Translesion synthesis (TLS) is a DNA damage tolerance mechanism that utilizes specialized DNA polymerases to bypass UV and other replication-blocking DNA lesions, often leading to mutagenesis. Somatic mutations resulting from TLS of unrepaired UV lesions are the major causes for essentially all skin cancers, especially melanoma. This project is to elucidate how a chromatin feature is implicated in TLS and UV mutagenesis, which will be informative for identification of new targets for the treatment and/or prevention of cancers, especially melanoma.